Connectivity and function of inhibitory neurons in the primate visual cortex

SUMMARY
The goals and specific aims of the present Administrative Supplement application are unchanged
with respect to the parent R01 award. Here we request additional funds for unanticipated
expenses within the original scope of the project. In the original application we proposed to use
viral vectors that specifically infect somatostatin (SOM) and parvalbumin (PV) inhibitory neurons
in non-human primate cortex. These viral vectors were generated and provided by our
collaborators Dr Zemelman at UT Austin (a subcontract PI in the first two years of the project), Dr
Dimidschstein (Broad Institute), and Dr Horwitz (Univ. of Washington). In the first two years of the
project, we tested and validated the 3 types of PV-specific viruses generated by our collaborators.
Dr Dimidschstein’s virus showed the highest specificity for PV neurons. Unfortunately, however,
Dr Dimidschstein has recently left academia and is no longer in a position to provide us with this
vector and its variants at no cost. We have, therefore, started a collaboration with Drs Gordon
Fishell (Harvard) and Dr. Gabrielle Pouchelon (Cold Spring Harbor) to generate variants of the
Dimidschstein PV-specific virus that express the necessary genes to perform the TRIO
experiments proposed in Aim 1 of the project, to trace anatomical inputs to PV cells. Moreover,
we are working with private companies (Genewiz and Addgene) and the U Penn Viral Vector Core
to generate variants of this PV-specific virus carrying the genes for excitatory and inhibitory
opsins; these are necessary to address Aim 3 of the project. These new approaches require
significant additional expenses which we cannot cover with the funds awarded. The requested
cost increases would allow us to address part of Aim1 and Aim3 of the project using vectors with
>90% specificity as validated by our studies performed in the initial years of the project. We will
make accessible to the community the vectors generated with the additional funds.

Public health relevance
NARRATIVE Normal brain function depends on the orderly development of circuits in the cerebral cortex and on their intact function. Knowledge of the normal circuitry provides a foundation for understanding the causes of impaired brain function and developing corrective measures. Our studies of the normal circuitry involving inhibitory neurons in early visual cortical areas will provide greater insight into the causes and effects of central vision defects when these circuits are damaged by stroke or other neurological or developmental cause. Moreover, our studies of inhibitory neuron function will provide a foundation for understanding the consequences of their dysfunction in neurological and psychiatric disorders, such as seizure disorders (Zhang et al., 2009; Halabisky et al., 2010; Peng et al., 2013) and schizophrenia (Hashimoto et al., 2003; Volk et al., 2012), which have been associated with alterations in gene expression, abnormal function or anatomy of distinct types of inhibitory neurons, including PV and SOM neurons.